A comprehensive investigation of Pseudomonas quorum sensing regulatory relationships and the consequences on quorum sensing inhibitors in complex communities

Our overarching goal is to develop efficacious strategies to combat multidrug-resistant (MDR) pathogens, a
growing healthcare threat. Quorum sensing (QS) inhibition is an attractive anti-microbial approach, as it
represents an anti-virulence strategy fundamentally different from current traditional therapies. QS a highly
conserved bacterial communication signaling regulatory mechanism controlling numerous virulence functions
and inter- and intraspecies interactions in mono- and polymicrobial communities. The recalcitrant ESKAPE
pathogen Pseudomonas aeruginosa (PA) exemplifies a highly problematic nosocomial pathogen with astounding
complex interconnected QS systems controlling multiple virulence functions and regulating antagonism or
synergism with other microbes. QS relevance in pathogenesis has been recognized; however, the regulatory
interrelationships of these systems during infection and in polymicrobial settings have been studied primarily in
vitro, limiting relevance to the human environment during infection and leaving answered fundamental questions
that will aid in combatting MDR infections by utilizing the anti-virulence/anti-QS approach.
We hypothesize that the interrelationships between the three QS systems are significant drivers of
infection severity, interspecies interactions, and microbial community composition. In turn, we anticipate that our
anti-QS lead compound will restrict infection exacerbations and promote microbial homeostasis.
We propose to assess this hypothesis paradigmatically by leveraging an extensive collection of PA QS
mutants and a novel anti-QS compound in dynamic and human-relevant host environments to identify
specific infection-relevant host-microbe and microbe-microbe interactions and dissect the mechanisms
underlying these interactions. Specifically, in the proposed three Aims, we will address three fundamental
questions that will fill existing gaps: 1) What are the regulatory relationships and functions of the three major PA
QS systems? 2) How do anti-QS therapies impact infection severity and QS regulatory interactions in PA mono-
and polymicrobial settings? and 3) How do the QS systems and inhibitors impact the development of resistance
and limit perturbations of host-associated microbial communities? Answering these questions will not only
provide critical insights into long-standing questions about the anti-virulence approach and the role of QS
mutations in PA virulence but will also uncover how the in vivo environment impacts the regulatory
interrelationships of the three QS systems and QS-dependent inter- and intraspecies interactions.
By tapping into bacterial QS pathways with novel potent and highly specific anti-QS compounds, we aim
to treat infections while preserving the composition and protective function of the microbiota. Results from these
dynamic settings may aid in the fight against antibiotic resistance and provide fundamental insights into the
molecular mechanisms underlying the virulence of complex infections and microbial interactions in vivo.

Public health relevance
This application’s long-term goal is to generate novel, efficacious strategies to combat challenging to treat multi-resistant bacterial infections. This study focuses on elucidating complex inter- and intraspecies bacterial interactions to uncover crucial insights about mechanisms bacteria use to synergize and compete in a human-like environment. These interactions using human-relevant microenvironments have not been addressed before.